2025 Tissue Microstructure Imaging Gordon Research Conference and Gordon Research Seminar

The biannual Gordon Research Conference (GRC) on Tissue Microstructure Imaging provides a unique forum for researchers characterizing cellular and sub-cellular tissue structure using various biomedical imaging modalities. This GRC brings together leading imaging researchers, who would otherwise not meet in scientific meetings, to facilitate discussions, share knowledge, and collaborate on advancing the understanding of tissue microstructure in physiology, pathology, development, aging, diagnosis, and treatment response.
The 2025 GRC “Function and Dysfunction within the Tissue Microstructure” covers microstructural imaging of various tissues, addressing both fundamental and clinical questions. The meeting objectives are:
Fundamental: To offer a unifying outlook at the tissue microstructure based on complementary vantage points, and to stimulate cross-pollination and validation of different techniques, models, and analysis tools.
Practical: To compare and contrast different imaging methods regarding providing an accurate assessment of tissue structure, function, pathological/development/age changes, and response to treatment.
Social: To cultivate a vibrant, cross-disciplinary imaging community, and present unpublished findings, discuss, and foster collaborations between established and young investigators across imaging modalities.
The conference will include 9 scientific sessions (each with 2 to 3 speakers and a discussion leader), poster sessions, and discussions designed to facilitate close interaction between participants. By design, GRC meetings are small (~150 attendees) facilitating interactions and community feeling. Still, participants will be recruited to ensure a rounded group of junior and senior investigators representing academic, government, and corporate research programs. Students and postdoctoral fellows will be specifically encouraged to attend. Junior investigators will be included in the oral presentations. The support requested herein will facilitate the attendance (conference costs) of trainees and junior investigators, fostering the future of the field.
The 2025 Tissue Microstructure Imaging GRC will be held July 13-18, 2025, at Stonehill College, Easton, MA. The 2025 Chair (and 2023 vice-chair) is Olivier Couture PhD (Research Director, Sorbonne University), pioneer in super-resolution ultrasound. The vice-chairs are Ileana Jelescu PhD (Assistant Professor, Lausanne University), expert in brain microstructure imaging using diffusion MRI and Marios Georgiadis PhD (Instructor, Stanford University), expert in X-ray phase contrast and combination with MRI and optics. To promote the participation and professional development of trainees, the GRC will be preceded by a Gordon Research Seminar (GRS) (July 15-16) organized by trainees: Mariam Andersson PhD (postdoctoral fellow Copenhagen University) and Sovesh Mohapatra (PhD student, U Penn). The multifaceted program will benefit scientists at all levels and will promote participation of junior investigators, trainees, and newcomers to the field.

Public health relevance
Public Health Relevance Tissue microstructure refers to tissues' building blocks at micrometer scales, encompassing the hierarchy of structures like organelles, cells, and functional units, which give tissues their distinct functional properties beyond just being a solution of elements, proteins, lipids, and amino-acids, where significant physiological, developmental, and pathological changes occur. Since tissue microstructure is below the spatial resolution of clinical in vivo human imaging techniques like MRI, CT, and ultrasound, mapping it requires breakthroughs in model-based quantification techniques, super-resolution methods, and specific molecular contrasts, and innovations in methods such as electron microscopy, X-ray, light-sheet, and expansion microscopy. Our 2025 TMI GRC will unite leading scientists in all the above biomedical imaging fields with the goal to foster synergies and delineate optimal multimodal approaches to study function and dysfunction of different tissues and organs at micrometer scales, critical for defining pathology in any tissue, for diagnosing diseases, generating treatments, and assessing response to therapies.